The MIND-BC Study: MIND diet for Breast cancer Cognition

PROJECT SUMMARY
Cancer-related cognitive impairment (CRCI) is reported by up to 75% of breast cancer patients during treatment.
Notably, up to 33% of survivors experience CRCI up to 20 years post-treatment. CRCI can be devastating among
survivors, reducing return to work, self-confidence, social relationships, and day-to-day quality of life. Despite
the well-documented CRCI burden, few efficacious interventions exist for this population. Likely biological
mechanisms of CRCI include inflammation and oxidative stress, among others. Dietary interventions could be
highly disseminable and acceptable to survivors but to our knowledge, none have been evaluated for CRCI. The
“Mediterranean-DASH Intervention for Neurodegenerative Delay” (MIND) diet has been shown to improve
neurocognitive outcomes (i.e., global cognition, working memory, verbal recognition memory, attention) and
preserve brain structure (i.e., inferior frontal gyrus, a key region of language production) in randomized clinical
trials (RCT) of women with obesity, adults with hypertension, and/or older adults at risk for Alzheimer’s disease.
In an RCT in the New England Journal of Medicine, both the MIND diet and mild caloric restriction were
associated with statistically significant improvements in overall cognition in overweight older adults with a family
history of dementia. The MIND diet provides rich sources of polyphenols, vitamins (e.g., B6), and minerals (e.g.,
zinc) that act as anti-inflammatory and antioxidants. Thus, the MIND diet may target the putative mechanisms of
CRCI. In the current study, we will conduct the first fully powered RCT to evaluate the efficacy the MIND diet
among people with cancer. Breast cancer survivors who have completed adjuvant treatment 6 months to three
years previously and reporting CRCI and low adherence to the MIND diet (N=200) will be randomized 1:1 to a
12-week feeding trial of the MIND diet versus their usual diet. Assessments will occur immediately before
(baseline) and immediately after the 12-week feeding trial intervention (informed by previous RCTs showing
cognitive benefits within this timeframe in non-cancer samples). To evaluate the longer-term effects of the MIND
diet, we will also conduct a 3 month follow-up assessment. Assessments include: 1) self-reported cognitive
functioning (i.e., subjective cognition), 2) a battery of neurocognitive tests (i.e., best objective performance), and
3) cognitive ecological momentary assessment (EMA) or smartphone-administered neurocognitive “brain
games” in daily life (i.e., usual objective performance). Consistent with the notion that subjective cognition is the
most clinically-relevant measure of CRCI, it will be evaluated as the primary outcome. Assessments will also
include 24-hour recalls and food frequency questionnaires as measure of dietary intake, QOL, and body
composition. Blood and stool will be collected at all three timepoints. Blood will be analyzed for change in putative
biological mechanisms of CRCI (e.g., inflammation) and nutrient biomarkers. Stool will be banked for future
analysis. Positive findings from this well-powered RCT would have high clinical impact for the many 2.3 million
breast cancer survivors living with CRCI.

Public health relevance
PROJECT NARRATIVE The “Mediterranean-DASH Intervention for Neurodegenerative Delay” (MIND) diet has been shown to improve neurocognitive outcomes (i.e., global cognition, working memory, verbal recognition memory, attention) and preserve brain structure (i.e., inferior frontal gyrus, a key region of language production) in randomized clinical trials of women with obesity, adults with hypertension, and older adults at risk for Alzheimer’s disease; however, no studies have explored the effects of the MIND diet in a cancer population which may have individual and additive effects that target systemic factors associated with cancer related cognitive impairment (CRCI). We will be the first to conduct a MIND dietary intervention among breast cancer survivors, a population with well-documented CRCI for which few efficacious interventions exist. Positive findings from this well- powered randomized clinical trial would have high clinical impact for the 2.3 million breast cancer survivors living with CRCI.